The association between the urine microbiome, the host immune response and urinary symptoms in children with spina bifida

Catherine Forster, MD, MS is a pediatrician in hospital medicine whose overarching career goal is to be a
world-recognized leader on UTIs in children with neuropathic bladder.
Research: Despite the importance of urinary tract infections (UTIs) to health outcomes in children with
neuropathic bladders, there are currently no methods to accurately diagnose UTIs in this population. This
proposal will begin to fill that gap. The goals of this proposal are to identify children who should be tested for a
UTI, develop a highly specific diagnostic method for UTI using mouse models, and translate these results into
a pilot cohort of children. These goals will be attained through completion of the following specific aims: 1)
Develop an algorithm based on clinical characteristics to determine the probability of UTI in children with spina
bifida; 2) Identify the relationship between urine microbial diversity and urinary biomarkers in mouse models of
neuropathic bladder; and 3) Explore the association between UTI and urobiome diversity and/or urine
biomarkers in children with spina bifida. Aim 1 will be completed through use of data from the multi-institutional
Urologic Management to Preserve Initial Renal Function Protocol for Young Children with Spina Bifida study.
Aim 2 will use both genetic and surgical mouse models of neuropathic bladder. In Aim 3, the urobiome and
urine biomarkers will be measured in symptomatic children with spina bifida.
Career Development: Together with her mentors, Dr. Carl Bates and Dr. Nader Shaikh, Dr. Forster has
created a career development plan built upon her prior training that is designed to address the areas where
she requires additional training: Gain additional knowledge around mouse bladder studies and genetic models
of bladder disease, create and maintain a mouse colony, gain experience with interpretation of urodynamic
data, develop working knowledge of bioinformatic approaches to analyze 16S rRNA sequencing data, and
develop expertise with recruiting and collecting prospective urine samples from a cohort of pediatric patients.
The proposed training plan will provide Dr. Forster with the necessary skills to validate the results of this work.
Environment: This research will take place within the Children’s Hospital of Pittsburgh (CHP). The proposed
career development plan utilizes the intellectual resources available through the University of Pittsburgh and
CHP, including the Center for Microbiome and Medicine, and nationally recognized seminars and courses.
Summary: This proposed innovative research will expand the evidence base for the diagnosis of UTI in
children with spina bifida. Aligned with NIDDK’s mission, this work will be an important contribution to
improving the health of children with neuropathic bladders. Dr. Forster's research and clinical training, prior
research experiences, and dedicated mentorship team make her ideally suited to pursue this research. This
award will facilitate Dr. Forster’s continued development into an independent investigator in the conduct of
research of the optimizing the care and outcomes of children with neuropathic bladders.

Public health relevance
Project Narrative Urinary tract infections (UTIs), a frequent problem in children with spina bifida, are notoriously difficult to diagnose in this population. The goal of this research is to first develop a method to identify which children with spina bifida are at high risk for a UTI, and then develop a more accurate way to diagnose UTIs in this population. The results of this research will lead to more appropriate antibiotic use, thus tempering the rising rate of UTIs with antibiotic-resistant organisms seen in children with spina bifida.